Mechanisms of metabolic adaptation after traumatic brain injury

PROJECT SUMMARY / ABSTRACT
Traumatic brain injury (TBI) results in life-long cognitive and motor disabilities. TBI elicits acute and
prolonged metabolic adaptations in an attempt to provide physiological fuel and to enable the survival
of damaged nervous tissue. The overall objective of this proposal is to determine the mechanisms of
metabolic adaptation to injury and the metabolic requirements that promote recovery following TBI.
The pathophysiology of TBI is complex and characterized largely by dysregulated glucose
metabolism. However, brain contains high concentration of fatty acids, which are liberated from
plasma membrane following TBI and further propagate secondary injury by promoting inflammation
and lipid peroxidation. We have shown that brain is capable of utilizing these fatty acids for energy
and metabolism via β-oxidation. Specifically, this mechanism is present in neural progenitor cells and
astrocytes. Thus, this mechanism allows to re-direct fatty acids to mitochondria for β-oxidation.
Importantly, our preliminary data show that fatty acid oxidation is increased following traumatic brain
injury. We hypothesize that the injured brain requires the up-regulation of fatty acid oxidation
specifically in astrocytes in order to spare glucose for neurons as well as eliminating toxic fatty acid
intermediates following damage to nervous tissue and blood brain barrier. Using tissue specific
transgenic and knockout mouse models, we will test this hypothesis and detail these fundamental
unanswered questions. To test these hypothesis we propose three specific aims: 1) Determine the
spatial and temporal contribution of brain fatty acid metabolism following TBI; 2) Determine the
requirement for brain fatty acid oxidation following TBI; 3) Determine the requirements for systemic
metabolic adaptations following TBI. The long-term goal of this project is to determine the regulation
and requirement for fatty acid oxidation pathway following TBI. Thus, these studies will elucidate how
fatty acid metabolism is regulated following the injury and advance our understanding of metabolic
adaptations. Furthermore, the fundamental knowledge how fatty acid metabolism is altered after TBI
could lead to targeted therapies to improve brain energy and metabolism after neurological insult.
!

Public health relevance
Project Narrative Traumatic brain injury (TBI) causes life-long disabilities including impairments in memory and learning. These disabilities are in part due to damage of the brain ability to metabolize glucose for energy. This proposal is relevant to public health because it will determine the extent to which the brain can also use fatty acids for energy and repair. Once this can be determined, new therapeutic approaches for treating the damaged brain can be developed. Thus, the proposed research is relevant to NINDS's mission to reduce the burden of neurological injury, and promote functional recovery and better quality of life for TBI patients.